Project 1: Streamlined identification of PAHs/PACs in environmental samples using ultracompact spectroscopy platforms and machine learning strategies

Project 1: Project Summary
Exposure to polycyclic aromatic hydrocarbons (PAHs), polycyclic aromatic compounds (PACs), per-and
polyfluoroalkyl substances (PFAS) and volatile organic compounds (VOCs) have all been identified with a large
number of human health risks. Current analytical techniques to detect and identify the chemicals in these families
are invariably slow, complex, and require expensive instrumentation and extensive sample preparation. We
propose an entirely new approach to the chemical detection and identification of environmental contaminants in
complex mixtures. Our strategy combines optical spectroscopic techniques such as Surface Enhanced Raman
Spectroscopy (SERS) and Surface Enhanced Infrared Absorption (SEIRA), combined together on a single
platform, fully integrated with Machine Learning (ML) algorithms, to advance the detection of chemicals in these
families of environmental contaminants. We plan to build on the results from our current grant period, where we
showed that individual chemical components in complex mixtures can be identified by a combination of
spectroscopic signatures of the chemical mixture combined with ML, an approach we call “Computational
Chromatography”. Having demonstrated computational demixing and identification of the components in simple
chemical mixtures, we plan to focus our efforts on expanding this technique to identify multiple individual
components in more complex, real-world samples. This will be accomplished by high-throughput spectral
sampling to refine the accuracy and complexity of our ML algorithmic approaches. In comparison with PAH
identification, PAC identification is substantially more challenging, since a single PAH may be converted by
multiple processes in the environment to several different PACs, some of which may be more far more water
soluble and bioactive than their PAH precursor. Relative to PAHs, PACs are far less well characterized. We
plan to develop an experimental-theoretical capability of predicting and verifying PAC spectra for oxo-PAHs and
nitro-PAHs, for chemical detection and identification equivalent in accuracy to that of the PAHs in complex
mixtures. We also plan to develop chemically-specific nanoantenna-based sensors that can be tailored to detect
specific chemicals of interest, based on IR-active antenna structures designed for identifying a targeted chemical
of interest. We will pursue this approach for rapid identification of PFAS from biological and environmental
samples. These approaches will also be extended to the identification of VOCs, where a combination of “purge-
and-trap” capture strategies will be utilized and combined with our computational chromatography approaches
for rapid VOC identification. The ultimate outcome of this project is the creation of streamlined, ultracompact,
ultrasensitive chemical analysis and detection platforms, capable of identifying multiple biological/environmental
contaminants of interest in a single sample without costly separation and purification steps, which could be
potentially transitioned to fieldable use.

Public health relevance
Project narrative The goal of this project is to achieve detection sensitivities similar to analytical techniques such as GC-MS, using new, nanoengineering-based approaches to chemical detection and identification of PAHs and PACs based on surface-enhanced vibrational spectroscopies. Combining the optically active nanoengineered substrates with ultracompact photocurrent detection technology, could greatly facilitate and accelerate the evaluation of superfund sites and their environmental and biological impact, and will also help in risk assessment by partnering with EPA and ATSDR.